Acute-to-Chronic Transition in Ergonomic Muscle Pain: Nociceptor Mechanisms

Abstract
Chronic musculoskeletal pain is a very common and frequently disabling condition that affects up to 50% of the
adult population worldwide, having a huge impact on quality of life and economic burden, loses related to
medical expenses, lower labor productivity and increased compensation claims. Unfortunately, our lack of
understanding of the mechanisms underlying this condition has precluded the development of rationale, safe
and effective therapies. While some people display resilience to chronic musculoskeletal pain, research has
only focused on the psychological aspects involved in such resilience. However, growing evidence suggests
that, in addition to psychological factors, a physical component is critical to achieve resilience to chronic pain
and that failure to display adequate reparative and/or regenerative responses is associated with persistent
pain. The phenomenon of repeated bout effect (RBE) is a common and natural example of the involvement of
an endogenous reparative response (i.e., physical resilience) to muscle injury and persistent pain. Initial
exposure to strenuous muscle activity produces significant pain, loss of force and tissue damage, which over
time resolves without any external intervention. Re-exposure to the same activity, will however, produce much
less pain, dysfunction and tissue damage, suggesting that physical resilience is enhanced by the muscle
activity. Although recent research has underlined the importance of immune, endocrine and neural responses
in muscle repair and regeneration, whether they also contribute to recovery from persistent musculoskeletal
pain is unknown. Furthermore, whether exposure to stress or repetitive ergonomic tasks interferes with
physical resilience, leading to chronic musculoskeletal pain, remains unknown. We plan to combine our
expertise in several experimental approaches and our new preclinical model of RBE to study physical
resilience, to achieve the three major goals of this proposal: (1) elucidate the role of muscle activity in physical
resilience, with emphasis on mechanisms of ergonomic injury-induced chronic muscle pain; (2) evaluate the
interaction between stress and physical resilience on chronic musculoskeletal pain, especially in regard to the
role of early-life interventions on physical resilience and muscle nociceptor hyperexcitability; and, (3) assess
the effect of physical resilience on neuropathic muscle pain, with emphasis on cellular and molecular
mechanisms of muscle nociceptor dysfunction.
!

Public health relevance
PROJECT NARRATIVE While strenuous physical activity produces muscle damage and pain, re-exposure after recovery attenuates these negative outcomes. This physiological adaptation depends on intrinsic muscle repair and regeneration capacity, which is modulated by factors such as age, stress, and timing and intensity of re-exposure to injury stimuli. By studying the mechanisms underlying such physical resilience the proposed work could provide a foundation for novel approaches for the diagnosis and treatment of chronic musculoskeletal pain.